The biological effect and the mode of action of the CXCL7-CXCL12 chemokine heterodimer

ABSTRACT
Chemokines are essential in health and disease such as infections, autoimmune diseases, atherosclerosis,
HIV/AIDS, and cancer. Many chemokines engage in heterophilic interactions with each other to form
heterodimers, leading to synergistic activity enhancement or reduction dependent on the nature of heterodimer-
forming chemokines. The mode of action of chemokine heterodimers remains poorly understood. Previously, we
identified all platelet-derived chemokines interacting with the two most abundant platelet chemokines, CXCL4
and CXCL7. The CXCL12 chemokine demonstrated strong heterodimerization with CXCL7. In the current
project, we will determine the biological consequences of these new interactions and the mode of action of the
CXCL7-CXCL12 heterodimer. In aim 1, we will determine the effect of CXCL7-CXCL12 heterodimerization on
CXCL12-mediated activities, that the CXCL7-CXCL12 heterodimer binds and activates the CXCL12’s receptor
CXCR4, and the molecular mechanism underlying the effect of the CXCL12-based heterodimers on cell
migration. In aim 2, we will determine the effect of CXCL7-CXCL12 heterodimerization on CXCL7-mediated
activities (neutrophil adhesion and migration) and the involvement of the CXCR2 receptor in CXCL7-CXCL12
heterodimer-mediated activities. The results of this project will deepen our understanding of chemokine biology
and inform the future development of novel therapeutic intervention strategies exploiting heterophilic chemokine
interactions.

Public health relevance
PROJECT NARRATIVE Chemokine are essential players in health and disease, including infections, autoimmune diseases, atherosclerosis, HIV/AIDS, and cancer. This proposal is directly related to public health because it will investigate the biological role of CXCL7-CXCL12 chemokine heterodimers. The results of this project will deepen our understanding of chemokine biology and inform future development of novel therapeutic intervention strategies on how to utilize heterophilic chemokine interactions.